Project 2

Project Summary - Project 2
The objective of Project 2 is to investigate the complex interplay of virus genetics and host immunity in
determining epidemiology and outcome of infection with Lassa virus, Ebola virus, and SARS-CoV-2. Our
central hypothesis is that both host and virus factors play key roles in determining the severity of clinical
outcomes including survival, disease severity and the development of long-term sequelae. To test this
hypothesis, we will investigate viral genetics, development of host immunity, and how these processes
interact as a result of viral infection or vaccination. In focusing on the host-pathogen interface, we will
complement the host-focused studies from Project 1 to better understand the complex factors that
determine the clinical outcome and epidemiology of Lassa, Ebola, and COVID-19.
To accomplish this, we will complete the following: In Aim 1, we will reﬁne viral sequencing techniques to
generate large catalogs of Lassa virus and SARS-CoV-2 genomic diversity. We will then integrate these
data with environmental and demographic data and apply phylodynamic models to identify virus
mutations and variants most likely to have an eﬀect on disease severity. In Aim 2, we will perform single
cell sequencing and transcriptomics to deeply characterize the evolution of adaptive immunity in
response to acute Lassa virus infection or vaccination. We will also isolate monoclonal antibodies from
individuals previously infected with or vaccinated against Lassa virus, Ebola virus, or SARS-CoV-2 to
understand the diversity of the human humoral response. In Aim 3, we will extend the multi-omics work
proposed in Aim 2 to individuals infected with diﬀerent viral variants, with the goal of developing a
predictive model of immune response and clinical outcome. This model will integrate the systems
serology data from Project 1 as part of a framework of repeated cycles of experimental data generation,
integration, application, validation, and reﬁnement to identify predictive biological markers of human
disease and outbreak dynamics. Finally, in Aim 4, we will validate the ﬁndings from the previous aims in a
BSL-4 setting (the biosafety level required for working with live Ebola or Lassa virus) and use the results of
animal models to further reﬁne our predictive models of clinical outcome.